Mechanistic insights into multifaceted roles of coronavirus exoribonuclease complex

As SARS-CoV-2 continues to wreak havoc across the globe, it is imperative to understand the mechanism and
regulation of the viral genome replication and transcription, which are essential processes in coronavirus life
cycle and represent important targets for therapeutic interventions. Coronavirus genome replication and
transcription are carried out by a dynamic replication-transcription complex (RTC), assembled from an array of
viral non-structural proteins (nsps). Within the RTC, a unique proofreading exoribonuclease (ExoN) complex,
nsp14-nsp10, boosts replication fidelity by excising mis-incorporated nucleotides and many antiviral nucleotide
analogs. In addition to its role in proofreading viral RNA synthesis, the ExoN complex is also involved in viral
RNA 5′ capping, which is critical for immune evasion by coronaviruses. Despite extraordinary efforts in studying
coronavirus biology and replication, major gaps remain in our understanding of the key roles ExoN complex
plays in various fundamental aspects of coronavirus life cycle. First, it is unclear how ExoN complex coordinates
with the low-fidelity viral polymerase to proofread RNA synthesis. Second, it is poorly understood how ExoN
complex is modulated by viral cofactors. Third, it is unknown how the two different enzymatic functions, RNA
cleavage and capping activities, of ExoN complex are coupled in the virus life cycle. The central objective of
our proposed experiments is to fill these gaps in understanding through a systematic dissection of the structural
basis and functional roles of ExoN complex and its dynamic interlay with viral cofactors in viral RNA synthesis
and processing. We will use SARS-CoV-2 as a model system and employ a combination of cryo-electron
microscopy, single-molecule biophysics, protein-RNA biochemistry, and cell virology to achieve this central goal
through the following aspects: Project 1, coordination of polymerase and exoribonuclease during mismatch
correction. We will define the mechanism by which RNA mismatches are transferred from polymerase to ExoN
and identify the molecular determinants for their functional interplay. Project 2, modulation of ExoN complex by
viral cofactors. We will elucidate the molecular details of the interaction between ExoN complex and a key RTC
subunit, nsp8, and determine how this interaction modulates the proofreading activity of ExoN complex during
mismatch correction. Project 3, coupling of RNA exonucleolytic digestion and 5′ capping activities of ExoN
complex. Building on our newfound cryo-EM structure of a dimeric form of the ExoN complex in which its RNA
digestion and capping activities are coupled, we will determine the molecular and biochemical underpinnings
and establish the physiological significance of the functional link between the two enzymatic activities of ExoN
complex. Through this research program, we will reveal the principles and molecular details governing the
multifaceted roles of this unique viral RNA proofreader and provide new insights into the mechanisms and
regulation of coronavirus genome replication and transcription. More broadly, the established tools and
experimental platforms are readily applicable to studying other RNA viruses.

Public health relevance
PROJECT NARRATIVE Coronavirus exoribonuclease (ExoN) complex is essential for the virus life cycle and represents a promising target for anti-coronavirus therapies. However, many fundamental aspects of this unique enzyme remain uncharacterized. This proposed research program aims to delineate the structural and molecular basis of multiple key processes mediated by ExoN complex during SARS-CoV-2 genome replication and transcription, which will provide insights into the development of new therapeutic strategies to fight the current and future coronaviruses.